Neonatal RSV infection and alteration of allergic immune responses

Abstract
The developing immune response in infants is central to establishing a balanced system that reacts
appropriately to infectious stimuli but does not induce altered disease states with potential long term sequelae.
Respiratory syncytial virus (RSV) is often the first clinically relevant pathogen encountered in life and has been
suggested to alter the immune system, affecting future responses, such as those leading to childhood allergies
and asthma. Other early life processes also contribute to the development of immune responses including
assembly of the microbiome, which appears to have a particularly important role early in life and significantly
altered after RSV infection in our studies. Our preliminary data show that early neonatal infection with RSV
alters bone marrow-derived dendritic cells (DC) at 4 weeks of age suggesting an prolonged altered innate
immune phenotype due to the early RSV infection. When neonatal RSV infected mice are sensitized to
allergens at 4 weeks of age, mice show an exacerbated allergic disease phenotype compared to those that
were not infected. These latter data reflect clinical findings where neonates have increased risk of severe RSV
infection and those most severely infected have an increased incidence to develop allergic disease during
childhood. Our preliminary data also highlight that the change in DC function is associated with major shifts in
the neonatal RSV-induced bacterial community composition of the gut and changes in plasma metabolite
profiles, most notably xanthine/uric acid metabolites. In the present proposal our hypothesis is that neonatal
RSV infection alters the local and systemic immune responses through alteration of the microbiome
that is coincident with changes in systemic metabolite production profiles that promote altered
programming of DC leading to increased susceptibility for the development of allergic disease. We
have provided strong preliminary data that demonstrate that early life RSV infection of the lungs alters the
development of the systemic immune responses in neonates, leads to gut microbiome alteration, and changes
the systemic metabolic profile of the neonate. In particular, our data suggest that the xanthine/uric acid
metabolic pathway that feeds into inflammasome activation is highly upregulated and is associated with the
altered microbiome during RSV infection. As uric acid promotes inflammasome activation and upregulation of
IL-1β and other inflammatory mediators we propose that this pathway will significantly contribute to the long-
term effects on the immune system. These early events modify impact the progression of allergic responses
systemically later in life through the long-term alteration of immune cell phenotypes. The investigation of the
mechanisms that govern these responses will establish new paradigms to be tested in patient populations and
represent a significant gap in our understanding of how infectious organisms alter the developing neonatal
immune system.

Public health relevance
PROJECT NARRATIVE The investigation of the mechanisms that govern neonatal immune responses being explored in this proposal will establish new paradigms to be tested in patient populations and represent a significant gap in our understanding of the developing neonatal immune system. The impact of neonatal respiratory syncytial virus infections on the development of the microbiome and changes in metabolites that influence allergic disease will be also examined to identify novel pathways of disease development.